Core B: Scientific Core

PROJECT SUMMARY
Our broad, long-term objectives are to supply reagents, models and expertise from a
centralized Science Core facility to all participants of the Program Project. Core operation
represents a balance between providing services based on established procedures, and
continued innovation in methods and protocols. Safety is a particular guiding principle of
the Core, and is addressed by the many years of experience of Core participants in the
study of prion diseases, facilities for safe homogenization and other biohazard operating
procedures, prion handling and decontamination. Protocol standardization is another
crucial goal, so that all aspects of the Program Project have access to reagents and
services produced and operated using consistent methods from a constant, reliable
source. The Science Core proposes five Specific Aims to accomplish this goal: Aim I will
produce and supply characterized mouse models of prion disease and tissues from those
mice; Aim II will supply purified anti-PrP monoclonal antibodies (mAbs) with well-defined
properties; Aim III will supply preparations of purified infectious prions; Aim IV will quantify
prions using sensitive, high throughput cell-based assays; and Aim V will perform detailed
biochemical, biophysical and structural studies of prion strains. The Science Core has
shown itself to be capable of adapting to efficiently incorporate elements of previous Core
structures as well as providing expanded state of the art facilities, techniques and skills
for the entire Program Project. The longstanding experience of the Core Co-Directors, Dr.
Telling and Dr. Soto, and Associate Director Dr. Bian, is a significant strength. The Science
Core resides in outstanding environments for studies of prion diseases. Studies within
individual Projects will be conducted in close collaboration with the Science Core to take
advantage of the availability of models and expertise, standardized and consistent
methodologies, and uniformly consistent, high quality reagents. The activity of the Science
Core is essential for the successful accomplishment of Program goals.